EFFECTS OF LIGHT ON LUTEINIZING HORMONE EPISODIC SECRETION

Test the hypothesis that pulsatile release of luteinizing hormone, which is controlled by episodic release of gonadotropin releasing hormone by hypothalamic arcuate nucleus cells, can be synchronized by a cycle of bright and dim light.